The role of heterogeneity among extraocular motor neurons for eye movement control

PROJECT SUMMARY
Developmentally-defined subtypes of motor neurons with specialized anatomical and functional properties
are required for facilitating movement. Exploring the relationships among developmental, anatomical and
functional properties of spinal motor neuron subtypes unveiled fundamental insights into the mechanisms
governing locomotion. It is not yet clear to what extent these organizing principles shape motor control outside
the spinal cord. Extraocular motor neuron subtypes are similarly anatomically and functionally diverse. Defining
the links between development, anatomy, and the role in behavior for individual extraocular motor neurons and
how heterogeneity shapes population function is crucial for uncovering the fundamental principles underlying
motor system organization.
To date, the complexity and developmental inaccessibility of most vertebrate models precludes linking
anatomy, birthdate, and function of extraocular motor neurons, thereby limiting our understanding of their
individual and collective contributions to behavior. Using the small and accessible model vertebrate – the larval
zebrafish – where functional extraocular motor neuron subtypes are genetically accessible therefore provides a
unique opportunity to test the hypothesis that general principles organize vertebrate motor systems. Our lab’s
previous work links motor neuron pool identity to birthdate and evaluates function by engaging the vestibulo-
ocular reflex. My preliminary data indicates that, when mature, extraocular motor neuron responses vary
considerably within individual motor pools.
The goal of this proposal is to reveal the organization within heterogenous populations of
extraocular motor neurons, and to define the behavioral impacts of such variability. Aim 1 will reveal the
generality of principles that link developmental, anatomical, and functional properties of individual motor
neurons. Aim 2 will define if/how heterogeneity within a population contributes to behavior, illuminating how
subtypes of motor neurons work together to control movement. As my long-term goal is to investigate the
neural basis of movement in health and disease, this work is foundational training on my path to an
independent position. Beyond training, my data stand to speak to the generality of principles of spinal motor
circuit organization. Completion of these experiments will take a critical step towards understanding motor
system development and function in health and disease.

Public health relevance
PROJECT NARRATIVE General organizing principles specify how anatomically and functionally distinct subtypes of spinal motor neurons control locomotion. To test for general principles underlying vertebrate motor circuit organization, the proposed research stands to reveal the functional organization within heterogeneous populations of extraocular motor neurons, and define the behavioral impacts of such variability. Therefore, this proposal is an important step towards understanding motor system development and function in health and disease, aligned with the NIH’s mission to increase fundamental knowledge of the mechanisms of disease, disorders, and dysfunction that impair health.